Develop a novel multi-approach dynamic Spot Scanning Proton Arc optimization framework

Project Summary
Spot-scanning Proton Arc (SPArc) therapy is an emerging treatment modality that has shown potential clinical
benefits for a wide range of disease sites. Unlike the conventional step-and-shoot multi-field Intensity Modulated
Proton Therapy (IMPT), SPArc therapy utilizes arc trajectories for planning and treatment. The extra degree of
freedom offers superior dose conformity which is particularly crucial for treating head and neck squamous cell
carcinoma (HNSCC) patients, where organs-at-risk (OARs) are often adjacent to the target volume. Therefore,
sharp dose fall-off using SPArc therapy is able to reduce radiation-induced toxicity. In 2018, the concept of SPArc
therapy was successfully demonstrated in a clinical Proton Therapy System (PTS) equipped with a
synchrocyclotron accelerator and partial gantry. This breakthrough drew significant interest from the radiation
oncology community. However, the clinical implementation of SPArc therapy faces several challenges. (1) Slow
optimization speed: Because of the mathematical complexity and optimization burden associated with numerous
spot and energy layers, it takes hours to optimize a treatment plan; (2) Prolonged treatment delivery time: Various
PTS have different machine-specific delivery sequences (MSDS) such as synchrotron, cyclotron, and
synchrocyclotron accelerators. It makes it almost impossible to generate a universal delivery-efficient plan across
all the different PTS. Some treatment times could be doubled because the key plan parameter does not fit the
specific type of PTS even with an identical plan that worked for another PTS; (3) Dose errors in the dynamic
treatment delivery: The accuracy of proton beam therapy is heavily reliant upon beam angle and its associated
water-equivalent-path because of the sharp distal fall-off. Delivering the dose continuously during gantry rotation
could cause unnecessary dose error between the "true" dynamic delivery and the static nominal plan, leading to
the degradation in local tumor control probability by about 5% for the HNSCC patient population. To overcome
these impediments and enable the clinical implementation of SPArc therapy on a global scale, this project will
develop a novel multi-approach dynamic SPArc optimization framework that ensures fast optimization, efficient
treatment delivery, and accurate dosimetry for various types of PTS. The project includes three specific aims:
(Aim 1) Systematically investigate machine-specific delivery sequences of various PTS and establish SPArc
simulators; (Aim 2) Develop a fast sparsity optimization framework; and (Aim 3) Introduce “true” dynamic
sequencing SPArc optimization framework and assess the improvement in the treatment delivery accuracy. The
results of this study will provide the first-of-its-kind SPArc delivery simulator and an open-source SPArc sparsity
optimization framework, benefiting global investigators and researchers and facilitating prospective clinical trials.

Public health relevance
Project Narrative This proposed project aims to develop the first-of-its-kind dynamic Spot-scanning Proton Arc (SPArc) optimization framework, providing users with fast optimization, efficient treatment delivery, and accurate dosimetry plans for various types of Proton Therapy Systems (PTS) equipped with synchrotron, cyclotron, and synchrocyclotron accelerators. This work will establish a cornerstone and guide in Treatment Planning System (TPS) development, supporting future multi-institutional prospective clinical trials and routine clinical implementation. If successful, this technique will significantly enhance treatment efficiency, accuracy, and clinical outcomes for a wide range of disease sites, to improve care and treatment of patients.